Immunosuppressive Network of Human Hepatocellular Carcinoma

DESCRIPTION (provided by applicant): Hepatocellular carcinoma (HCC) is the second leading cause of cancer deaths worldwide. Tumor immune effector and suppressive responses have been linked to improved and poorer clinical responses, respectively. Preliminary data in this proposal demonstrates that hepatic antigen presenting cells (APC) expressing inhibitory B7 family members contribute to the immune suppressive network in human HCC. The long term goal of this project is to define the HCC immune suppressive network and its contribution to HCC progression as well as its therapeutic implications. In addition, biological insight into the function of resident APC subsets within the human liver and interaction with other T cell subsets will translate knowledge to other disease states such as chronic viral hepatitis, autoimmune hepatitis, and transplantation. The overarching hypothesis for this project is that HCC tumor factors promote or recruit inhibitory APC subsets that control the immune suppressive network utilizing inhibitory B7 family member function. This proposal will integrate data obtained from human HCC tissues, peripheral blood, clinical data from HCC patients, and murine models of HCC. The nature of APC subsets, relevance of B7 family members, and mechanisms of their actions in the immune suppressive network will be explored.

Public health relevance
PUBLIC HEALTH RELEVANCE: The treatment options for HCC are limited and there is currently only one known medical therapy for HCC. Immune regulation is increasingly being recognized to occur in the tumor microenvironment and contributes directly to tumor immunopathogenesis. However, the cellular and molecular mechanisms that render an immune suppressive network in HCC are incompletely understood. This proposal is devoted to defining the nature and functionality of these newly described B7 family members and the unique biology of APCs, T cells, and NK cells within the human liver and HCC. A further understanding of these dynamic processes will allow for future development of targeted immunotherapies for HCC as well as a better understanding of how best to tailor current therapies and surveillance programs to patients at risk for developing HCC. Research Relevance The treatment options for HCC are limited and there is currently only one known medical therapy for HCC. Immune regulation is increasingly being recognized to occur in the tumor microenvironment and contributes directly to tumor immunopathogenesis. However, the cellular and molecular mechanisms that render an immune suppressive network in HCC are incompletely understood. This proposal is devoted to defining the nature and functionality of these newly described B7 family members and the unique biology of APCs, T cells, and NK cells within the human liver and HCC. A further understanding of these dynamic processes will allow for future development of targeted immunotherapies for HCC as well as a better understanding of how best to tailor current therapies and surveillance programs to patients at risk for developing HCC. __SpecificAimsTextDelimiter__ Specific Aims Hepatocellular carcinoma (HCC) is currently the fifth most common malignancy and the second most common cause of cancer related deaths in the world. While HCC is the most common primary liver malignancy in the world, the U.S. incidence has also been rising. Recurrence occurs in 20-40% of patients undergoing liver transplantation or resection of cases, with the rate increasing to greater than 90% in tumors with poor histologic features such as vascular invasion. Known medical therapies are scarce for patients not eligible for hepatic regional therapy, with only one medication, sorafenib, able to extend median survival on the order of a few months. Increasing focus has been applied to tumor immunity controlling tumor progression or resulting in the development of "tumor tolerance" while other investigations have begun to examine immunotherapeutic approaches. Tumor immune responses are important in that immune effector and suppressive responses have been linked to improved and poorer clinical responses, respectively, for HCC as well as in other tumors types. Understanding the nature of tumor factors contributing to suppression or activation is critical to the development of future immunotherapeutics as well as optimizing known therapies for HCC. Preliminary data in this proposal demonstrates that antigen presenting cells (APC), particularly Kupffer cells (KC) contribute to the immune suppressive network within human HCC. KCs expressing high levels of inhibitory B7 family members, such as B7-H1, mediate a suppressive phenotype by controlling effector responses via one of the receptors for B7-H1, PD-1. Intratumoral B7-H1 levels, T regulatory cells (Treg), and T effector cells are independent predictors of outcome in human HCC. However the mechanisms by which these phenotypes arise and the contributions that hepatic resident APC subsets make to this phenotype in human HCC is unclear. In addition, human hepatic APC subsets including KC and intrahepatic dendritic cells (DC) are believed to contribute to the overall toleragenic nature of the liver microenvironment in models or diseases such as transplantation, chronic hepatitis, and autoimmunity. Only recently have some of these APC subsets begun to be examined in a systematic manner. The long term goal of this project is to gain an understanding of how the HCC microenvironment controls APC phenotype and how that phenotype affects immune responses to HCC and consequent progression or response to therapies. The overarching hypothesis for this project is that HCC tumor factors promote or recruit inhibitory APC subsets that control the immune suppressive network utilizing inhibitory B7 family member function. This proposal will integrate data from human HCC tissues, peripheral blood, clinical data from HCC patients, and murine models of HCC. The nature of APC subsets, relevance of B7 family members, and mechanisms of their actions to the immune suppressive network will be explored in the following specific aims: Aim 1: Determine the integration of APC subsets, inhibitory B7 function, and Treg function in the HCC and hepatic microenvironment. 1.1) To determine the dominant APC subset in HCC utilizing B7 member function for immune suppression. 1.2) To define individual effects of inhibitory B7 family members on T effector, T helper, and Treg subset function. 1.3) To evaluate the role of Treg on control of APC B7 inhibitory function. Aim 2: Determine the controlling mediators of B7 family cognate receptor function on T cell and NK cell subsets within the HCC and hepatic microenvironment. 2.1) To determine which T cell and NK cell subsets express receptors for B7 family members. 2.2) To evaluate which cytokines and other factors regulate receptors for B7 family members on T cell and NK cell subsets. 2.3) To determine the functional relevance of B7 receptor expressing T cell and NK cell subsets. Aim 3: Determine the clinical relevance of inhibitory B7 function in the HCC and hepatic microenvironment. 3.1) To determine the impact of B7 functional blockade on APC and T cell function within HCC and tumor development. 3.2) Evaluate the prognostic significance of B7 and B7 receptor function to response of therapies to HCC.